Neurostimulation Enhanced Cognitive Restructuring for Transdiagnostic Emotional Dysregulation: A Component Analysis

This application proposes the addition of data collection and hypotheses for the parent R01 in support of the
training of a very promising graduate student from an under-represented background. Using data from a
completed pilot study in individuals with emotion dysregulation, our team has shown that task-based functional
activity and connectivity in the insula are associated with induction of negative emotion, utilization of emotion
regulation skills, and emotion dysregulation severity. In a comparison group of non-clinical participants,
utilization of emotion regulation skills was associated with increased functional connectivity strength between
the insula and the mPFC, a default mode network node. These findings suggest that dynamics between the
salience and other large-scale prefrontal networks differ between emotionally dysregulated and non-clinical
participants. Therefore, the supplement plans to examine the hypothesis that cortico-insular connections are
critically involved in emotion dysregulation and may be a mechanism for the therapeutic response to
neuromodulatory perturbation. Ms. Gerlus is planning to learn and employ a connectomic approach to
determine how cortico-insular connectivity is related to emotion dysregulation and affected by brain stimulation.
The skills and training proposed would allow her to establish the foundation for a physician-scientist career at
the intersection of psychiatry and neuroscience and would serve as the basis for her dissertation.

Public health relevance
Project Narrative Neurostimulation is a promising method for treating emotion dysregulation, a symptom that contributes to transdiagnostic psychiatric distress and is associated with insula dysfunction. Given that the neurostimulation efficacy is related to the precision of stimulation at a specific cortical target, understanding the neural mechanisms of emotion dysregulation will lead to improved transdiagnostic brain stimulation interventions. With the goal of optimizing therapeutic neuromodulation, proposed studies will investigate the role of insular resting-state and task-related functional network connectivity in transdiagnostic emotion dysregulation and brain stimulation therapy for dysregulation.